UNC Oncology Clinical/Translational Research Training Program (OCT-RTP)

Abstract
In this competing renewal, the University of North Carolina at Chapel Hill (UNC) Divisions of Adult
and Pediatric Hematology/Oncology, the Department of Radiation Oncology and the UNC
Lineberger Comprehensive Cancer Center (UNC LCCC) seek renewed funding for the UNC
Calabresi K12, called the Oncology Clinical/Translational Research Training Program (OCT-
RTP). All of the components will contribute mentors and resources to the training program, and
all components except the LCCC will contribute scholars. The OCT-RTP will admit two scholars
per year. The PI, Dr. Norman Sharpless, is the Wellcome Distinguished Professor in Cancer
Research and Director of the LCCC. Dr. Sharpless has extensive experience in oncologic
translational research. Dr. Hanna Sanoff, Associate Professor of Medicine and Section Chief of
GI Medical Oncology, is an experienced mentor who assumed the role of Program Director (PD)
in 2016. The program's objectives are to establish a rigorously trained cadre of researchers who
will become successful, independent cancer investigators. Training resources available for the
OCT-RTP include: the LCCC, the North Carolina Cancer Hospital and the UNC Clinical and
Translational Science Award (CTSA) which supports an Education, Training, and Career
Development Core. The goals of the OCT-RTP are to increase the quality and quantity of patient-
oriented cancer research. The foundation of the proposed training program will be the
participation of highly qualified basic science and clinical mentors assigned to each scholar with
mentoring activities coordinated by the K12 leadership. An internal advisory committee (IAC) that
includes senior faculty from the program components will select and monitor scholar progress,
while an external advisory committee reviews the program annually. Since its inception, the OCT-
RTP has enrolled sixteen Scholars, including 10 funded in the last grant cycle whose records are
detailed in the progress report. Major changes since our last renewal include a new PD (Dr.
Sanoff), changes in the composition of the IAC, greater integration with other UNC training
programs, and changes in the mentorship roster. In particular, the mentor roster has been pruned
from 40 to 34 mentors to enhance research focus, with the addition of new mentors adding a
greater diversity of now-relevant expertise, including notable additions in patient-reported
outcomes, data analytics and novel clinical trial design. Facilities and resources for the program
have evolved to provide even stronger support, including the leveraging of considerable state
support from the University Cancer Research Fund (UCRF). We believe these changes and
growth have strengthened a successful and important training program.

Public health relevance
Project Narrative The rapid pace and multidisciplinary nature of translational cancer research has heightened the need for robust training of the next generation of cancer scientists. The purpose of the K12 program at UNC is to facilitate the development of motivated scientists able to conduct rigorously designed research anchored in sound scientific theory, who will ultimately become the next generation of independently funded cancer researchers and mentors. While in the K12 program, scholars from the fields of radiation oncology, adult and pediatric oncology will work with senior investigators in Lineberger Comprehensive Cancer Center to develop an individualized training program including course work and grant writing support, complete an intensive mentored research project, and ultimately apply for individual extramural funding.